Indoles from commensal microbiota promote mobility during aging

Abstract: Aging is associated with loss of mobility and also with dysbiosis, but it is unclear what microbiota products
contribute to health or frailty. We identiﬁed indole and its derivatives as molecules secreted by benevolent commensal
bacteria that act across diverse phyla (C. elegans, Drosophila, mice) to augment healthspan and allow animals to live better
for longer. Our preliminary and published data suggest that as animals age, indole acts via the Aryl hydrocarbon receptor
[AHR] to limit sarcopenia and maintain mobility in aged animals; speciﬁcally, indoles limit the loss of critical sarcomere
proteins as well as A- and I-bands within the muscle sarcomere. Citing our work as impetus, a recent metabolomic study
using samples from the Osteoporotic Fractures in Men [MrOS] cohort found that loss of indole-producing bacteria reduced
plasma indole levels and correlated with decreased mobility in aged humans. We hypothesize that indole promotes stability
of muscle proteins essential for the contractile apparatus by promoting chaperone-mediated refolding of damaged proteins,
or by regulating proteasome activity to promote loss of irreparable proteins and/or limiting aggregation of damaged proteins.
We identiﬁed another indole-regulated process in muscles that may aLect motility during aging. Speciﬁcally, indole restores
youthful expression of genes associated with mitochondrial respiratory function and eLiciency that fuel muscle activity.
Indole also limits mitochondrial fragmentation in aging muscle, a process associated with reduced ATP production and
increased reactive oxygen species [ROS] production. We hypothesize that during aging, indole (i) regulates the proteostasis
machinery, including both chaperones and the ubiquitin-proteasome system [UPS], to refold or eliminate damaged
sarcomere proteins and preserve myoﬁbrils; and (ii) upregulates mitochondria respiration and reduces ROS production, to
maximize ATP production and limit damage to sarcomeres. Our Aims determine how indole limits sarcomere and
mitochondrial damage, maintains muscle mass and function, and promotes mobility during aging. Aim 1 determines the
mechanism by which indole limits age-dependent loss of existing assembled myoﬁbrils via upregulating the levels of the
myosin chaperone UNC-45 and the UPS. Aim 2 determines how indole maintains or improves mitochondrial function and
morphology during aging to fuel muscle activity and limit ROS damage to myoﬁbrils. Aim 3 uses genetic approaches to
identify additional cellular pathways regulated by indole that promote mitochondrial or sarcomere stability and motility
during aging. We use genetic and biochemical analysis in the nematode Caenorhabditis elegans, whose striated muscles
exhibit signiﬁcant structural conservation with mammals. Importantly, aging C. elegans exhibit loss of mobility and changes
in proteostasis, including loss of the contractile apparatus and mitochondrial function, characteristic features of sarcopenia
in mammals that are mitigated by indole. Here, we also propose to corroborate our worm results in aged mice. Together,
these studies will provide mechanistic information on how indole derived from commensal bacteria counteracts sarcopenia
during aging. These studies are essential for developing indoles as biomarkers for frailty and health, and as possible
therapeutics to treat sarcopenia and other forms of muscle wasting in the elderly.

Public health relevance
Project narrative: Loss of muscle mass and function causes decreased mobility, falls, and fractures in elderly people, and though no e7ective therapy currently exists, chemical compounds called “indoles,” derived from the gut bacteria or diet, limit decline in muscle function and mass and promote mobility in aging animals. We will determine how indoles protect the muscle contractile machinery during aging (Aim 1), how indoles preserve the mitochondria, the powerhouse of the cell whose function becomes dysregulated during aging (Aim 2), and the identity of additional indole-regulated pathways that enhance mobility during aging (Aim 3). These studies will facilitate development of indoles as therapeutics for elderly people at risk for falling or losing mobility.